Strategies and Opportunities to Stop Colon Cancer in Priority Populations

DESCRIPTION (provided by applicant): The federal government has set a Healthy People 2020 goal of a 70.5% screening rate for colorectal cancer (CRC), but almost half of eligible U.S. adults are not up to date on their screenings. Among minority and low-income populations, the CRC screening rate is extremely low. To address this disparity, we will develop and test a culturally tailored, health care system-based program to improve CRC screening rates in OCHIN, a community-based collaborative network of more than 200 Federally Qualified Health Centers (FQHCs). Racial and ethnic minorities, along with low-income and medically underserved populations, increasingly receive their primary care at FQHCs, which serve nearly 19 million patients annually throughout the United States. OCHIN is the largest national FQHC network. Its integrated electronic health record system combining medical, laboratory, and claims data will serve as a novel and robust data source for our study. In Phase I (Year 01), we will pilot-test an evidence-based approach to improving participation in CRC screening in two OCHIN FQHCs. This phase will include an assessment of the intervention's feasibility, effectiveness, and cost. In Phase II (Years 02-05), we will conduct a comparative effectiveness pragmatic clinical trial, using a mixed-methods approach to evaluate the adoption, implementation, and maintenance of our CRC screening program designed explicitly for FQHC clinics. Throughout the project, we will work with a diverse planning advisory group of OCHIN clinicians and patients, community representatives, state policy makers, and researchers, using principles of Community-Based Participatory Research. Because OCHIN is the largest single FQHC network and serves patients who are diverse in race, ethnicity, and insurance status, our results will play a transformative role in accelerating CRC screening research in underserved populations. Our program will expand meaningful use of electronic health information; synergistically meet national goals to improve cancer screening rates, address health disparities, and reduce health care costs; and act as a catalyst for future systems-based approaches to improve care delivery in FQHCs and other health systems.

Public health relevance
PUBLIC HEALTH RELEVANCE: Colorectal cancer (CRC) is the second-leading cause of cancer death in the United States. Rates of CRC screening are extremely low in patients at Federally Qualified Health Centers (FQHCs), which serve nearly 19 million patients annually. We will test an intervention to improve rates of CRC screening in a group of FQHCs. We intend for our program to be a model for other FQHCs and health systems. Colorectal cancer (CRC) is the second-leading cause of cancer death in the United States. Rates of CRC screening are extremely low in patients at Federally Qualified Health Centers (FQHCs), which serve nearly 19 million patients annually. We will test an intervention to improve rates of CRC screening in a group of FQHCs. We intend for our program to be a model for other FQHCs and health systems. __SpecificAimsTextDelimiter__ 2a. SPECIFIC AIMS (for Phase 1, UH2 Planning Phase) The Healthy People 2020 target for colorectal cancer (CRC) screening is 70.5%, yet almost half of eligible U.S. adults are not screened at recommended intervals. Equally alarming are large disparities between rates of CRC screening in general populations and those in minority and underinsured populations, particularly those who receive care in Federally Qualified Health Centers (FQHCs). Previous research showed that in an age- eligible predominantly Hispanic and African-American FQHC population, the CRC screening rate was as low as 7%.4 Among FQHC patients, 70% have incomes at or below the federal poverty level, and 62% are racial or ethnic minorities.2 With more than 8,000 FQHCs serving 19 million patients annually, low rates of CRC screening in these clinics result in a significant number of CRCs that are undetected or detected only when the prognosis is poor. The proposed research leverages the expertise of a research team that has successfully implemented numerous interventions in both FQHC and integrated health care settings. It takes advantage of the existing community laboratory of OCHIN, a network of over 200 FQHCs. OCHIN is the largest network of FQHCs in the United States that are linked by the same electronic health record (EHR). It spans 12 states and provides care to more than 1 million patients. Our primary goal is to markedly increase CRC screening rates in large numbers of diverse patients by devising and testing an intervention that uses a low-cost fecal test. Phase I will be a milestone-driven planning phase to pilot-test the intervention in two FQHCs. Phase II will be a large-scale, cluster-randomized controlled pragmatic trial built on the foundation and methods established in Phase I. In Phase II, we will expand the pilot to ~22,000 patients across 18 clinics in the OCHIN network. A central planning advisory group of key OCHIN clinicians and patients, researchers, and policy-makers will guide the planning and pilot study implementation. In both phases, our researchers and analysts will participate in national Workgroups of the Collaboratory. Phase I aims include: Aim 1. Define electronic codes and methods to identify eligible patients and track relevant CRC outcomes. a. Define inclusion and exclusion criteria for study participation to identify a set of patients at two pilot OCHIN clinics who are at average risk for colorectal cancer. b. Define data sources and refine methods for extracting EHR data on socioeconomic and demographic variables, receipt of CRC screening tests, results, receipt of follow-up care, and diagnoses. c. Determine potential moderators of intervention effectiveness-e.g., Hispanic ethnicity, native language, and insurance status-and create codes that can extract EHR data relevant to these moderators. Aim 1 milestones: (a) identification of a prospective cohort of potential study participants; (b) creation of a set of OCHIN-specific codes that will allow selection of eligible patients for recruitment and tracking of relevant outcomes (receipt of CRC screening test, screening test results, receipt of follow-up care); (c) creation of a list of codes to analyze potential moderators of study effectiveness. Aim 2. Use codes and methods developed in Aim 1 to test the feasibility, effectiveness, and cost of an EHR- based, two-arm CRC screening intervention in a subset of 100 patients in the pilot clinic. Aim 2 milestones: (a) creation of a validated, EHR-linked CRC screening registry to track total mailings of fecal immunochemical test (FIT) kits, test results, and receipt of follow-up care; (b) assessment of the pilot intervention's reach and effectiveness based on number of FIT kits mailed and the number completed; (c) development of cost collection and metrics and assessment of the pilot intervention's preliminary cost. Aim 3. Use results from the pilot intervention to prepare a large-scale, cluster-randomized pragmatic trial across 18 OCHIN clinics (see Phase II). Aim 3 milestones: (a) successful selection of 18 clinics whose combined patient populations are representative of the overall FQHC population; (b) development of clinic recruitment materials and a manual outlining trial protocols (including randomization procedures and quality assurance protocols), scopes of work, and associated budgets. Raising CRC screening rates in the rapidly increasing population of patients seeking care at FQHCs will help address a serious disparity in cancer screening-and thus cancer treatment-in the United States. Fecal tests for CRC are among the most cost-effective cancer screening tests available, with recent evidence suggesting they are cost saving. The proposed innovative pragmatic trial addresses an important evidence gap because it is large scale and unique in using systems-level, sustainable methods to raise CRC screening rates in FQHC populations-a diverse group of patients of several ethnic subpopulations with some of the lowest CRC screening rates in the United States OCHIN network of FQHCs.